Scaling-Up Integrative Pain Management in Federally Qualified Health Centers

PROJECT SUMMARY
Background: Chronic pain impacts a fifth of American adults. Integrative pain management (IPM)
interventions including mindfulness-based stress reduction, yoga, and other methods have demonstrated
improvements in pain and function, and are now included in clinical guidelines for chronic pain conditions.
Despite evidence of efficacy, IPM is not reaching low-income populations at greatest risk for chronic pain and
related opioid overdose. Low-income communities rely on safety-net healthcare facilities to access care, of
which Federally Qualified Health Centers (FQHCs) are the primary providers. The Integrative Medical Group
Visit (IMGV) for chronic pain is one of a few promising IPM interventions developed specifically for safety-net
settings. The challenge now is to examine effectiveness and implementation of IMGV in FQHC settings, to
address chronic pain and risks associated with opioid use. Goals and Objectives: Dr. Roth’s long-term career
goal is to become an independent investigator evaluating effectiveness and implementation of IPM
interventions to reduce the burden of chronic pain, particularly in low-income communities. This K01 career
development award will allow Dr. Roth to gain advanced skills in conducting trials that can identify successful
implementation strategies for IPM interventions. Career Development Activities: The K01 application will
provide structured didactic and hands-on training that will build on Dr. Roth’s training in community-based
participatory research and foundational implementation science skills, through training in cluster-randomized
trial designs, cost measurement and evaluation, and conducting a multi-site pilot study with FQHCs. The plan
will engage Dr. Roth in robust training activities including mentorship, coursework, research projects,
publishing and presenting, workshops and seminars, grant-writing, and responsible conduct of research.
Mentors: Dr. Roth’s mentorship team consists of accomplished scientists from implementation science, clinical
integrative health research, intervention epidemiology, health economics, and FQHCs. Environment: Dr. Roth
will benefit from a comprehensive research training program and infrastructure based at the UNC School of
Medicine’s Program on Integrative Medicine, the top-ranked UNC Gillings School of Public Health, and the
North Carolina Translational and Clinical and Sciences Institute. The North Carolina Community Health Center
Association will provide training in working with FQHCs. Research: Dr. Roth’s proposed K01 research project
will address the limited access to IPM in FQHC settings serving low-income patients. Dr. Roth will first engage
key stakeholders through implementation mapping to identify and refine implementation strategies (Aim 1).
She will then pilot measures of effectiveness and implementation for IMGV in two FQHCs (one rural, one
urban) in North Carolina (Aim 2). This award will prepare Dr. Roth to submit a future competitive grant
application for a hybrid type 2 effectiveness-implementation trial of IMGV for chronic pain in FQHC settings.

Public health relevance
PROJECT NARRATIVE Despite evidence of efficacy, Integrative Pain Management is not reaching low-income populations at greatest risk for chronic pain and related opioid overdose. This research and training plan will inform implementation of Integrative Pain Management interventions at scale, improving access to communities most at-risk.